Enriching Communication skills for Health professionals in Oncofertility and Trainers in Oncofertility Reproductive Communication and Health - Revision - 1

Adolescent and young adult (AYA) cancer patients have distinct medical and psychosocial needs, with
reproductive health being a chief concern.[1-5] Reproductive health for AYA cancer patients can include issues
such as infertility and fertility preservation (FP).[6] These issues takes on a different meaning in AYA who have
a poor prognosis/end-stage cancer or terminal diagnosis, for whom reproduction during their lifetime is deemed
unlikely. Coupled with the distinct needs of terminal AYA are those of their partners and caregivers, as decision
making around fertility can cause added distress. This poses unique ethical issues for clinicians in discussions
of FP. The use of gametes stored from the deceased is also fraught with ethical and legal issues, as policies
often do not exist, are inconsistent, or not well understood by the original donor or potential recipient. Although
rare, requests for peri-mortem gamete retrieval are also ethically challenging, particularly when clear
conversations and documentation about the patient's intentions for posthumous parenthood cannot or do not
occur. Finally, the recent Supreme Court ruling in Dobbs v. Jackson Women's Health Organization has raised
issues specific to creating and storing embryos for the purposes of FP given the “personhood” assigned to
embryos under some states' legislation.
While American Society of Clinical Oncology (ASCO) guidelines suggest all patients of reproductive age
should be offered counsel and referrals to specialists for FP, there is little guidance and great controversy over
such offers to patients with poor oncologic prognoses. Moreover, there is a dearth of guidance and regulation
regarding how to dispose or distribute stored gametes after patient death. The American Society of Reproductive
Medicine (ASRM) Ethics Committee suggests programs develop clear policies outlining the circumstances under
which they would participate in posthumous assisted reproduction(PAR).3 ASRM also recommends consent
forms include specific directions regarding posthumous use of embryos and gametes, including specifying a
bereavement period following the patient's death prior to the use of the patient's gametes or embryos. Despite
these strong recommendations, there is a lack of evidence supporting adoption of institutional policies. The legal
implications of recent political and judicial events may have also altered ability to adhere to existing policies. Our
goal is to build a framework for the consideration of the ethical, legal, and social implications (ELSI) of PAR and
distribution/destruction of stored gametes from deceased patients.
The parent grant, Enriching Communication skills for Health professionals in Oncofertility and Trainers in
Oncofertility Reproductive Communication and Health (ECHO -TORCH) provides communication strategies for
discussion reproductive health with AYA. This supplement will aid in expanding and improving ECHO-TORCH
with our current and future traineesThe proposed study aims to understand the perspectives of stakeholders
related to PAR and gamete disposition discussions and use.

Public health relevance
Project Narrative Reproductive health for AYA cancer patients can include issues such as infertility and fertility preservation and these issues takes on a different meaning among AYA with a poor prognosis/end-stage cancer or terminal diagnosis. This supplement will aid in expanding and improving ECHO-TORCH with our current and future trainees through understanding the perspectives of stakeholders related to PAR and gamete disposition discussions and use.